Fine-Tuning the Notch Signaling Pathway via O-Glucosylation

DESCRIPTION (provided by applicant): Notch signaling in an evolutionarily conserved pathway that regulates diverse processes in animals, including stem cell maintenance, cell fate specification, learning and memory, and angiogenesis. Maintaining an optimal level of Notch signaling is essential for normal human development and human health, as mutations that result in increased or decreased activity of the Notch pathway cause a number of human diseases, including cancer and developmental disease. Moreover, therapeutic manipulation of the Notch pathway activity is of great interest in Notch-related diseases and in regenerative medicine. We have identified an evolutionarily conserved enzyme called Rumi, which adds O-linked glucose to specific EGF repeats of Notch receptors and regulates Notch signaling in both Drosophila and mammals. Our data indicate that the number and distribution of O-glucose residues on the Drosophila Notch determines the strength of Notch signaling over a wide range, and that mammalian Notch signaling is sensitive to Rumi gene dosage is specific contexts. Our preliminary data indicate that addition of one or two xylose residue to O-glucose by newly identified enzymes can further regulate Notch signaling. Our data strongly suggest that the level and distribution of O-glucose and its extended forms on Notch tightly regulate the strength of Notch signaling. We will elucidate the mechanisms underlying the fine-tuning of the Notch pathway by carbohydrates by using a combination of Drosophila genetics, cell-based signaling assays and biochemical experiments. In the long run, this project has the potential to establish tools to alter the activity of Notch signaling by manipulating the level of O-glucose and xylose on Notch proteins.

Public health relevance
PUBLIC HEALTH RELEVANCE: Alterations in the activity of the Notch pathway cause important human diseases including cancer and developmental disorders. The proposed studies examine the role of glucose and xylose molecules in regulating the strength of Notch signaling.